Targeted CRISPR/Cas Editing to Eliminate SIV CNS Reservoir in Methamphetamine-Exposed Rhesus Macaques on ART

Summary
In the ongoing battle against HIV, current antiretroviral therapies (ART) fall short of providing a cure, primarily
due to latent reservoirs in the body, particularly in the central nervous system (CNS). Myeloid cells, including
microglia and macrophages (MM), serve as key cellular reservoirs in the CNS, perpetuating the infection by
releasing toxic viral proteins and inflammatory mediators. This persistent infection is further complicated by
substance use disorders (SUD), with methamphetamine (METH) use disorder (MUD) being notably prevalent.
METH exacerbates the situation by disrupting the blood-brain barrier (BBB), activating microglia, and triggering
the NLRP3 inflammasome, which leads to increased neuroinflammation and neuronal damage. Recent
advancements in CRISPR/Cas genome editing offer a glimmer of hope. This technology has shown promise in
preclinical studies for eradicating HIV provirus from various tissues, including the brain. The proposed research
aims to harness this potential by using a novel AAV serotype (R2Mac) capable of penetrating the BBB and
targeting MM. This serotype will deliver multiplex Sso7d-mediated enOsCas12f (SOS12f) editors to eliminate
HIV/SIV provirus and the NLRP3 inflammasome. The research will be conducted using a Rhesus Macaque
model of SHIV infection on ART, which closely mimics human conditions. The study will leverage the combined
expertise of Dr. Ling and Dr. Hu in nonhuman primate models, METH neurotoxicity, MM inflammasome,
CRISPR/Cas HIV eradication, and targeted gene therapy. The proposal includes two specific aims: first, to
determine the efficiency and specificity of the R2Mac-mediated multiplex SOS12f gene therapy in eliminating
SHIV provirus and inflammasome in SHIV-infected MM; and second, to evaluate the therapeutic efficacy of this
approach at analytical ART interruption (ATI) using the SHIV+ART+ model, both with and without METH
administration. This innovative approach, utilizing the R2Mac serotype and multiplex editing, holds the potential
to significantly advance our understanding and treatment of NeuroHIV and MUD, offering new hope for those
affected by these challenging conditions.

Public health relevance
Narrative Rhesus Macaque model of SHIV infection on ART (SHIV+ART+) is highly relevant to people with HIV who suffer from immune activation and inflammation due to persistent proviruses in various latent reservoirs. Substance use disorders, particularly methamphetamine (METH) use disorders, exacerbate HIV infection, replication, and neuroinflammation, leading to HIV-associated neurocognitive disorders (HAND). This project is significant for public health, as it aims to discover innovative targeted gene therapies to eliminate neuroinflammation and HIV cellular reservoirs in the brain, ultimately striving to cure NeuroHIV and address substance use disorders.